Use of Next-Gen Sequencing to Identify Genetic Variants that Influence compulsive Oxycodone Intake in Outbred Rats

Abstract
Our multidisciplinary and highly collaborative consortium has been identifying gene variants that are associated
with increased vulnerability to compulsive oxycodone use, tolerance to the analgesic effects of oxycodone, and
development of withdrawal-induced hyperalgesia by performing the first GWAS using an advanced model of
chronic intravenous oxycodone self-administration. We have also created the first preclinical oxycodone biobank
which enables researchers who do not have the resources to perform chronic intravenous self-administration or
next-generation genome sequencing to perform advanced genetic, molecular, and cellular studies to further our
understanding of the biological changes underlying addiction-like behaviors. However, we are facing significant
challenges that threaten the viability of this project due to rising labor and supply costs and the need for additional
data curation efforts due to equipment/software failures. The overall goal of the following two aims for this 12-
month supplement is to ensure the viability of the oxycodone biobank and provide an in-depth analysis and
curation of oxycodone addiction-like behaviors. This will address the increased costs of maintaining the
repository and the need for accurate and reliable data processing. In Specific Aim 1, we will ensure the continued
viability and expansion of the Oxycodone Biobank, which has become an invaluable resource for addiction
research. The rising costs of supplies, labor, and equipment maintenance threaten the sustainability of the
biobank, and this aim will focus on repairing and updating critical equipment, procuring essential supplies, and
covering the increased costs associated with maintaining the repository, including accommodating the increased
number of samples. In Specific Aim2, we will reanalyze the entire dataset affected by the MedAssociates
software errors. This will involve manually handling the raw data to recover accurate information and processing
it into our database. We will employ rigorous data curation protocols to ensure the integrity and accuracy of our
findings. This process will include systematic error-checking, data validation, and meticulous integration of
corrected data. By maintaining high standards of data curation, we will guarantee the reliability of our analysis
and interpretation, providing robust insights into oxycodone addiction-like behaviors. Integrating these curated
data with existing behavioral and genetic data, we aim to uncover novel insights into the mechanisms underlying
oxycodone addiction and develop more targeted interventions.

Public health relevance
Narrative This is a multidisciplinary, highly collaborative consortium that combines next-generation sequencing with state-of-the-art behavioral screening in a unique, genetically diverse, nonhuman animal model. The goals of this consortium are to identify gene variants that are associated with oxycodone use, the effects of oxycodone on analgesia and pain using genome-wide association studies (GWAS), and the sensitivity to FDA-approved treatments in behaviorally characterized heterogeneous stock rats, and to maintain a data/tissue repository (Oxycodone BioBank) accessible to all researchers to study the cellular and molecular mechanisms of oxycodone addiction. Results from these studies have the potential to have a sustained and powerful impact on the field of addiction because they will identify novel druggable targets, provide a comprehensive analysis of oxycodone addiction-like behaviors in males and females, and maintain a unique data/tissue repository that will facilitate follow-up and replication studies.